Neural effects of breathing training in obstructive sleep apnea

PROJECT SUMMARY
This proposal aims to investigate the neural mechanisms by which inspiratory muscle training (IMT) reduces
blood pressure (BP) in patients with obstructive sleep apnea (OSA). OSA affects over 10% of the population and
is a major risk factor for hypertension and cardiovascular disease. Traditional treatments like continuous positive
airway pressure (CPAP) have limited efficacy in lowering BP, creating a need for alternative approaches. Several
studies show that IMT, which involves breathing in against resistance, can meaningfully reduce systolic BP. The
training typically involves performing a daily set of 30 inhalations through a device that provides a fixed resistance
(a breathing trainer). The IMT practice only takes 5 minutes a day, and while it does not replace CPAP or other
treatments, it is popular with our patients. However, the mechanisms by which IMT lowers BP in OSA are
unknown. The hypothesis being tested in this proposal is that IMT lowers BP by reducing centrally-driven
sympathetic nervous system activity, which is often elevated in OSA patients. This proposal focuses on the role
of the insula, a brain region involved in autonomic regulation and sensory integration, factors likely impacted by
IMT. The project will assess whether IMT alters insula function and connectivity within the central autonomic
network brain structures, which could underlie a reduction in sympathetic tone and BP. We will use resting-state
functional magnetic resonance imaging (rsfMRI) connectivity to measure changes in insula connectivity, and
magnetic resonance spectroscopy (MRS) to measure insula levels of glutamate, a key excitatory
neurotransmitter. Since high sympathetic drive in OSA is likely being driven by high activity in the anterior insula
especially, we hypothesize a reduction in brain activity in this region, reflected as lower connectivity and lower
glutamate levels. The study will involve two groups of untreated, moderate or severe OSA patients with elevated
BP or stage 1 hypertension (bp ≥120/80 mmHg to <140/90 mmHg). Our target sample is 45 participants who
complete each arm, balanced for age and sex. One group will undergo 10 weeks of IMT at resistance 65% of
maximum, while a control group will train at resistance 15% of maximum. The specific aims are to assess: 1)
changes in insula connectivity with other brain regions involved in autonomic control, and 2) changes in insula
glutamate levels. We will consider potential confounds such as anti-hypertensive medication usage. The
hypothesis is that IMT will induce lower connectivity and lower glutamate levels compared to the control group.
We will monitor and control for potential confounds such as antihypertensive medications, drop-out, and
adherence. Overall, the findings will elucidate a potential neural basis of IMT’s impact on BP, offering insights
into both breathing training and other potential new interventions for hypertension in OSA patients.

Public health relevance
PROJECT NARRATIVE Obstructive sleep apnea (OSA) affects 15% of the population and is typically accompanied by high blood pressure (BP) that is difficult to treat, since BP does not reliably drop with either CPAP treatment or antihypertensive medications. A promising finding is that breathing resistance training reliably lowers BP, but why this happens is unclear. We propose investigating a possible mechanism by looking at whether a brain region that influences BP (the insula) shows a lowering of activity with 10 weeks of breathing training.